HYPERTONIC SALINE FOR INCREASED ICP FOLLOWING HEAD INJU*

DESCRIPTION (provided by applicant): Refractory intracranial hypertension is a leading cause of death in head injured children who reach the hospital alive. There is increasing evidence that hypertonic saline can reduce intracranial pressure (ICP) sufficiently if used as upfront therapy to avoid uncontrollable intracranial hypertension. A well-established relationship between adequate control of the ICP and outcome, methods to improve ICP control are still urgently needed. A pilot prospective randomized trial of standard therapy recommended by the American Association of Neurolological Surgeons, adjusted for children, and standard therapy plus hypertonic saline is proposed. 40 children will be randomized into the 2 groups. The primary outcome measure will be percent time that the ICP is greater than 20. Secondary outcome measures of efficacy will include the frequency of objective neuroworsening as defined by Morris et al., the 6-month Glasgow Outcome Scale, the COAT (Children's Orientation Amnesia Test), and the Divided Attention Test.